Regulation of cellular functions and innate immunity by interleukin-1alpha

Project Summary
The IL-1 subfamily members IL-1α and IL-1β both signal through the IL-1R1 receptor. The activation and function
of IL-1β has been described extensively in the context of inflammasome activation, which culminates in active
caspase-1 cleaving inactive pro-IL-1β to its active and secreted form. While pro-IL-1α can also be cleaved and
secreted by inflammasome activation, in contrast to IL-1β, pro-IL-1α is biologically active and is constitutively
expressed in epithelial cells. IL-1α exhibits dual functionality, acting as a traditional cytokine but also controlling
a number of diverse cellular functions. As discussed in this proposal, we have identified novel and physiologically
relevant functions of IL-1α in the context of innate immunity and inflammation, however the mechanisms by
which they are regulated is unclear. These novel findings reveal a number of fundamental knowledge gaps in
our understanding of IL-1α biology. In particular, the pathways by which IL-1α is released from dying cells are
largely unknown as is its ability to regulate inflammatory and cell death pathways. We will utilize crystalline silica
as a sterile inflammatory insult to interrogate these mechanistic questions. We have found that IL-1α in non-
hematopoietic cells plays a role in the recruitment of neutrophils to the lung in response to a sterile inflammatory
insult. Further, we show in vitro that IL-1α can bind specifically to the phospholipids cardiolipin and
phosphatidylserine. In epithelial cells, IL-1α co-localizes with phosphatidylserine and IL-1α is externalized
coincident with the movement of phosphatidylserine to the outer surface of the cell during apoptosis.
Phosphatidylserine exposure is an established “eat me” signal that identifies apoptotic cells for clearance by
macrophages through efferocytosis. We have found the presence of IL-1α on the surface of the cell blocks
efferocytosis, and propose this failure results in secondary necrosis of the epithelial cells, release of DAMPs,
and a physiologically relevant enhancement of inflammatory responses. Finally, we show the binding of IL-1α to
cardiolipin, once externalized on the mitochondrion by mitochondrial dysfunction, blocks the removal of damaged
mitochondria by mitophagy. We propose IL-1α binding to cardiolipin blocks its recognition by LC3b, a critical step
in mitophagy, thus preventing removal of damaged mitochondria. It is known that activation of the Nlrp3
inflammasome is triggered by mitochondrial damage and that downregulation of mitophagy results in enhanced
Nlrp3 inflammasome activation. We further propose that intracellular pro-IL-1α enhances Nlrp3 activation by
blockade of mitophagy. The completion of these studies will provide important insights into the regulation of the
innate immune response by the multiple cellular functions of IL-1α.

Public health relevance
Project Narrative IL-1α exhibits dual functionality, acting as a traditional cytokine but also controlling a number of diverse cellular functions. We will interrogate the mechanism by which IL-1α is released from dying cells and its modulation of innate immune responses through the regulation of efferocytosis and mitophagy. We will further determine if IL-1α-mediated stromal cell crosstalk and interference with cellular eat-me signals modulates inflammation and pathology induced by a sterile inflammatory insult.